A Biobehavioral Approach to Understand Problematic Avoidant/Restrictive Eating in Adults with Functional Dyspepsia

PROJECT SUMMARY/ABSTRACT
Functional dyspepsia (FD) is a chronic gastrointestinal functional/motility disorder that affects up to 12% of US
adults with significant morbidity and healthcare costs and has limited treatment options. Detrimental eating-
related medical consequences are frequent in FD, with a level of food avoidance/restriction meeting criteria for
avoidant/restrictive food intake disorder (ARFID) in up to 40% of adults with FD. However, the biological
mechanisms of problematic avoidant/restrictive eating in FD have been underexplored and could inform
behavioral and biological intervention targets. This 5-year K23-Patient-Oriented Research Career Development
award addresses this research gap by using an innovative, multi-disciplinary approach to examine: (1)
differences in gastric sensorimotor functions and satiety hormones among adults with FD and ARFID, FD
without ARFID, and healthy controls; and (2) pilot feasibility, preliminary clinical outcomes, and preliminary
mechanisms of an exposure-based cognitive-behavioral treatment in patients with FD and ARFID. This project
represents the first exploration of the mechanistic role of problematic avoidant/restrictive eating in FD and the
potential benefit of an intervention that exposes patients with FD to increased food volume/variety. The training
plan corresponding to this project will support Dr. Helen Burton Murray in becoming an independent clinical
scientist with a program of research examining biopsychosocial target mechanisms of gastrointestinal
functional/motility disorders to inform behavioral and biological treatment interventions. The study aims
complement Dr. Burton Murray’s objectives for her advancement as an independent clinical and translational
investigator, achieved through four training areas: gastric sensorimotor functions, endocrine regulation of
appetite, behavioral clinical trials evaluation and treatment mechanisms, and career development. Training
goals will be implemented under the guidance of Dr. Braden Kuo (primary mentor); Drs. Elizabeth A. Lawson
and Jennifer J. Thomas (co-mentors); Drs. Brjánn Ljótsson and Brian Healy (consultants); and Drs. Lukas Van
Oudenhove, Johnathan Williams, and Laurie Keefer (scientific advisory committee). The purpose of this
proposed supplement award is to provide Dr. Burton Murray with essential staff support during the
most active data collection year planned. Supplement support will preserve the success of Dr. Burton
Murray in achieving the above aims and facilitate her successful K-to-R transition.

Public health relevance
PROJECT NARRATIVE Functional dyspepsia (FD) is a chronic gastrointestinal functional/motility disorder which frequently poses detrimental and problematic eating-related medical consequences (e.g., significant weight loss, malnutrition) with avoidant/restrictive food intake disorder (ARFID) present in up to 40% of adults with FD. The parent award supports a two-part investigation to determine the role of problematic avoidant/restrictive food intake by (1) comparing gastric sensorimotor functions and satiety hormones among adults with FD and ARFID, FD without ARFID, and healthy controls, and (2) testing the feasibility, preliminary outcomes, and preliminary mechanisms of an exposure-based cognitive-behavioral treatment in a pilot randomized controlled trial. The proposed supplement award will provide the PI will essential staff support during the most active data collection year planned to achieve the above aims, and facilitate successful K-to-R transition.